Vital Status

SSA will extract vital status information from the following systems of records:
• Master Beneficiary Record, System of Records Notice (SORN) 60-0090;
• Master Files of Social Security Number (SSN) Holders and
SSN Applications, SORN 60-0058;
• Supplemental Security Income Record and Special Veterans Benefit,
SORN 60-0103; and
• Earnings Recording and Self-Employment Income System, SORN 60-0059.